Supplement to AWD000033276 - Tracy fellowship - childcare costs

PROJECT SUMMARY
No changes: request does not affect this document.

Public health relevance
PROJECT NARRATIVE No changes: request does not affect this document.